Renal Disease Epidemiology Training Grant

Kidney disease is highly prevalent and results in premature mortality, comorbid illnesses, reduced quality of
life, and substantial healthcare costs. Given the vast scope of the kidney disease epidemic, there is a critical
need to train scientists who can conduct high-impact research that addresses this massive health problem.
This proposal is a competitive renewal application, years 26 to 30, for a NRSA to fund our Kidney Disease
Epidemiology and Clinical Research Training Program at Hopkins. The goal of this program is to identify and
train scientists who have the potential to become leaders in the design and conduct of epidemiologic, clinical
and translational research related to kidney disease. The Program is based in the Welch Center for
Prevention, Epidemiology, and Clinical Research. It takes advantage of the faculty’s strengths in the
application of rigorous methodology to study kidney disease; their ability to design interdisciplinary, high-impact
research; and their dedication to education and mentorship. The program Director (Dr. Appel), Associate
Directors (Drs. Fadrowski, Grams, Segev), and 14 other nationally recognized kidney disease researchers
serve as core faculty, and another 11 faculty serve as affiliate faculty. An Advisory Committee of institutional
leaders and accomplished researchers advise the program’s leadership and monitor its progress.
Our training program has been highly successful. We have recruited exceptionally high-quality candidates,
provided them with rigorous training, and helped launch their research careers. Over the last 15 years, we
supported 31 post-doctoral trainees (77% women, 10% underrepresented minorities). Of the 25 graduates, 24
are pursuing academic careers, and the vast majority are scientists; 12 received federal grants (11 K
awardees). The NRSA funding has established Hopkins as a pre-eminent academic center for the design and
conduct of clinical, epidemiologic and translational research related to kidney disease; spawned new research
programs (e.g. the CKD Prognosis Consortium and the Kidney Transplant Outcomes program) and new
education initiatives (e.g. kidney disease epidemiology course); revitalized the Pediatric Nephrology fellowship;
forged close collaborative relations across schools and academic units; and most importantly, produced a
cadre of extremely successful young investigators who are doing innovative research at institutions across the
U.S. Still, we will not rest on our laurels. With funding from this application, we intend to increase the size of
our training program from 4 to 6 post-doctoral trainees, expand the core faculty (including luminaries recruited
from other institutions: D. Brennan, C. Chute, and C. Parikh), and enhance trainee recruitment efforts,
especially targeted at enrolling under-represented minorities. Ultimately, this T32 will meet a critical goal of
NIDDK, i.e. broadening the pool of well-trained researchers conducting impactful kidney disease research.

Public health relevance
The need for well-trained scientists to conduct impactful research on epidemiologic, clinical and translational aspects of kidney disease is substantial. The T32 Kidney Disease Epidemiology Training Program at Johns Hopkins has a stellar reputation for identifying and training researchers who can meet this need.